STONE FORMING RISK OF GRAPEFRUIT JUICE CONSUMPTION

The hypothesis is that grapefruit juice consumption confers protection against stone formation by increasing urinary citrate, magnesium, and pH, thereby reducing the propensity against the crystallization of stone-forming uric acid and calcium oxalate.